Kaiser Permanente NCI National Community Oncology Research Program, NCORP

Project Summary/Abstract
The Kaiser Permanente (KP) NCORP Community Site is committed to the principle that including community
providers and a representative patient population is essential to advancing oncology research. The KP NCORP
Community Site has decades of experience conducting cancer treatment clinical trials, care delivery, and
cancer control research. During the first funding cycle, the KP NCORP Community Site brought the benefits of
our broad community membership base, increased access/accrual to clinical trials, and conducted cancer care
delivery research. The KP NCORP Community Site was exceptionally successful with both total and specific
trial enrollment to studies with our affiliated research bases. In addition, KP NCORP Community Site clinicians
and population scientists served on numerous NCI and Research Base Steering, Scientific, and Working
Group Committees, making important contributions to the NCORP research agenda. In the next funding cycle,
we will continue to participate in this integrated national network of community organizations to increase the
involvement of community oncologists, other medical specialists, and our patients. Continued participation in
multi-institutional cancer control, prevention, and care delivery research, as well as quality-of-life studies
embedded within treatment and imaging studies conducted under the NCORP and NCTN, will benefit the
community at large. Our clinician and population scientists will continue to serve on NCI and Research Base
committees and provide insight into clinical significance, identifying care disparities, and provide input on
feasibility during protocol development. We will continue to recruit patients, including enrolling participants from
underrepresented populations.

Public health relevance
Project Narrative As a member of NCORP’s integrated network of community organizations and research bases, the Kaiser Permanente (KP) NCORP Community Site will bring medical advances to the community at large by increasing clinical trial access and accrual to cancer control, prevention, symptom management, imaging, treatment, and cancer care delivery research. KP’s integrated health plan presents an ideal platform for accelerating the translation of findings into clinical practice.